Preservation of muscle function through Schwann cell regulation of motor unit expansion

ABSTRACT. Preservation of muscle function through Schwann cell regulation of motor unit expansion
The loss of skeletal muscle mass and function with aging, known as sarcopenia, is a universal health challenge
for the growing elderly population, contributing to decreased mobility, increased disability, loss of independence,
and poor quality of life. Studies from our group and others have shown that disruptions of muscle fiber innervation
and a reduction in the number of motor units (MU) are significant factors in sarcopenia. A major compensatory
mechanism that preserves muscle under conditions of denervation, is MU expansion, which requires axon
sprouting and guidance from innervated to denervated neuromuscular junctions (NMJ). In this proposal we will
for the first time define cellular responses and molecular pathways critical for MU expansion with the goal
of facilitating the development of effective preventive and rehabilitative interventions that exploit this existing
protective process. It is widely accepted that axon growth between NMJs occurs through bridges formed by
proliferating terminal Schwann cells (tSCs). Exciting new data from our lab using experimental as well as
bioinformatic approaches point to the induction during MU remodeling of the secreted phosphoprotein 1 (Spp1)-
CD44-protein kinase C alpha pathway from myelinating Schwann cells (SC) onto tSCs. This signaling pathway
has not previously been studied in sarcopenia, but published reports show increased Spp1 levels in nerves
following denervation injury, the ability of Spp1 to induced SC proliferation through interactions with its receptor
CD44, and CD44 expression on tSCs that is increased with nerve injury and during ongoing denervation/
reinnervation in an animal model of amyotrophic lateral sclerosis (ALS). Collectively, rigorous preliminary and
published data strongly support SCs as critical effectors of MU expansion via signaling by Spp1. The goals of
this project are to establish the effects of age on this pathway in SCs, define the links between denervation and
Spp1 signaling, and determine whether this pathway can be targeted to develop protective and rehabilitative
therapies for muscle loss. Our overall hypothesis is that MU expansion requires a specific population of tSCs
that proliferate in response to denervation through Spp1 signaling mediated by CD44. Using a
combination of powerful mouse models, technically sophisticated surgical interventions and assessments of MU
properties, and rigorous multidisciplinary genomic and analytical approaches we will show (i) how the number
and function of various populations of SCs change with aging and loss of innervation, (ii) the patterns of
expression of Spp1 and its signaling partners during denervation and reinnervation, and (iii) the impact of altered
Spp1 signaling on MU expansion. By exploiting this physiological compensatory protective mechanism as a
therapeutic target, rehabilitative interventions may be developed to preserve muscle, prolong healthspan, and
improve quality of life during aging as well in the context of injury or degenerative neuromuscular and mobility
disorders, such as ALS. Successful completion of these aims will accelerate both advances in mechanistic
understanding of MU expansion and the ability to target those mechanisms for musculoskeletal rehabilitation.

Public health relevance
PROJECT NARRATIVE Age-related declines in muscle mass and function are key contributors to frailty, which is a major public health problem that significantly reduces mobility, increases disability, hampers independence, and raises the risk of falls and injuries among the elderly. The lack of understanding of mechanisms of muscle wasting and weakness represents a critical barrier to progress toward the development of successful interventions for ameliorating physical frailty and thereby improving quality of life in old age. Through the elucidation of mechanisms that allow muscle motor units to expand their size to rescue muscle fibers destined to be lost due to denervation, this project will provide insights into processes and pathways that may be targeted for the development of rehabilitation interventions that exploit existing compensatory protective mechanisms to preserve muscle, prolong healthspan, and improve quality of life.